PANCREATIC STENT VS OPERATIVE DRAINAGE OF PANCREATIC DUCT

To determine the safety and effectiveness of endoscopically placed internal stent drainage of the pancreas as compared to standard operative therapy for chronic pancreatitis.